New chemical probes enable Mass Spectrometry-based footprinting of human protein structure in lipid membranes and cells

The sensitivity, resolving power, and speed of modern mass spectrometers now afford the opportunity to develop
bottom-up footprinting methods capable of resolving significant structural and dynamics questions of membrane
proteins. This bottom-up approach is a fundamentally more powerful alternative to the top-down mass
spectrometry (MS) studies that have been mainly limited to bacterial membrane proteins. We focus on human
proteins because they participate in almost all physiological processes and represent more than 60% of drug
targets. They, however, represent the most challenging targets for traditional high-resolution structural methods.
Structures of about 100 of these proteins are known to date, leaving a large gap for footprinting MS to fill. Our
long-term goal is to develop comprehensive footprinting MS methods that offer a unique approach to structure
and dynamics of membrane proteins in live cells and in vitro lipid bilayers. Our objective here is to synthesize
new chemical probes that provide high footprinting coverage to reveal the ligand interaction and dynamic
transport motion of ferroportin, a model protein representing the largest superfamily of membrane transporters
and maintaining iron homeostasis in humans. Our hypotheses are: (1) Complementary chemistry can maximize
the coverage of footprinting and thereby improve its spatial resolution. Furthermore, tuning the physical
properties of the labeling reagents will allow access to the hydrophobic region of membrane proteins. (2) Photo-
activated fast footprinting can reveal dynamic transporter motions taking place within milliseconds, which is
beyond the current scope of membrane structure biology. (3) Bio-orthogonal irreversible labeling can be
optimized to reveal the cellular structure state of membrane proteins, a structure that is elusive by crystallography
or cryo-EM. Use of these conventional methods requires purified proteins, but most membrane proteins are
insufficiently stable to withstand demanding purification. Live-cell footprinting completely avoids this giant
difficulty. Our hypotheses are built on extensive preliminary data produced in our laboratories. Specifically, we
continue to demonstrate our capability to explore new chemistry and synthesize new reagents. Our ongoing
studies prove the principle that MS footprinting can reveal ligand-binding interaction of human membrane
proteins in lipid bilayer, and can report on their native structural state and motion in live cells. To accomplish our
goals, we will pursue three specific aims: (1) develop new chemical probes to provide high footprinting coverage
of membrane proteins; (2) implement the new probes in lipid membrane systems to study the ligand interaction
and millisecond motion of ferroportin; and (3) demonstrate the new probes' compatibility with live-cell footprinting
by the detection of cellular motions and ligand interactions of ferroportin. Our innovative footprinting coupled with
bottom-up MS proteomics analysis will establish effective, broad-based footprinting in live cells and lipid
membranes. The significance of the proposed approach will expand because MS-based footprinting can be
broadly applied by structural proteomics researchers to biomedically important human membrane proteins.

Public health relevance
The proposed research is relevant to public health because human membrane proteins represent more than 60% of the drug targets and participate in almost all physiological processes. With the development of mass spectrometry footprinting methods in lipid membranes and live cells, we will elucidate the native structure of a human membrane protein of cardiovascular importance, leading to the mechanistic understanding of its function and the rational design of novel drugs.